SINGLE ORAL DOSES OF SDZ DJN 608 IN NIDDM

To determine whether plasma and cerebrospinal fluid levels of HIV-1 rna are independently associated with the presence of symptomatic distal symmetrical polyneuropathy (DSP) and whether the levels correlate with pain intensity and to determine whether markers of immune activation (B2-microglobulin, TNFa, TNFr2, sICAM-1) are independently associated with symptomatic DSP and whether the levels correlate with pain intensity.